Contributions of Self-Focused Attention to Early Warning Indicators of CBT Non-Response

Project Summary/Abstract
Cognitive behavioral therapy (CBT) is the first-line psychological treatment for anxiety and obsessive
compulsive (OC) disorders, yet approximately half of patients who receive CBT fail to achieve sustained
clinical remission. Such failures are widespread but poorly studied and contribute to the escalating public
health burden of anxiety. To date, no reliable biomarker capable of detecting CBT non-response exists. In this
R01, we seek to fill this gap by collecting a battery of clinical, behavioral, self-report, and neural measurements
before, during, and after CBT in a large cohort of patients with anxiety and OC disorders and healthy controls.
Using these data, we will employ state-of-the-art machine learning techniques to build a model of CBT non-
response and to test the hypothesis that early changes in a specific biomarker, self-focused attention (SFA),
will represent a sensitive predictor and potential mechanism of CBT non-response. Prior research from our
group has identified a promising neuroimaging-based biomarker of SFA, characterized by abnormal resting
state functional connectivity between regions of the default mode network (DMN) and dorsal attention network
(DAN) in a transdiagnostic sample. Trait SFA showed sustained reductions by 6 weeks into treatment, which
tracked with clinical improvement, suggesting potential corresponding neural changes at that time. A common
limitation of prediction studies is that they typically assess predictors only at baseline, which provides limited
understanding of processes contributing to non-response and leaves unaddressed the question of what can be
done for those predicted to not respond. Given that for anxiety and OC disorders, substantial improvement
during CBT rapidly diminishes if not achieved early in treatment, we hypothesize that early changes in DMN-
DAN connectivity may represent a mechanism of non-response and contribute to an early warning system that
can be used to identify individuals at risk for suboptimal CBT response. This study will first establish the
reliability and construct validity of DMN-DAN connectivity as a measure of SFA, which is distinct from related
cognitive constructs, such as rumination, worry, and more general attentional mechanisms, such as attentional
control and orienting, in a subgroup of 50 patients and 50 matched healthy controls. Next, we will provide 12
weeks of standard CBT for 110 patients with anxiety and OC disorders. Neuroimaging data will be acquired at
baseline, week 6, and post-treatment to assess changes in functional connectivity throughout treatment. As
predictions of CBT response are unlikely to be a function of SFA alone, we will develop supervised machine
learning models that accommodate the hypothesized DMN-DAN connectivity measure, plus other data-driven
features, to predict response at post-treatment. Since our goal is not to use MRI scans clinically, the use of
machine learning to identify the strongest predictors of CBT non-response from a large set of multimodal
features throughout CBT may reveal potential proxy measures that do not require neuroimaging. This study will
reveal potential mechanistic indicators of CBT non-response that can guide treatment selection and planning.

Public health relevance
PROJECT NARRATIVE Cognitive behavioral therapy (CBT) is the most effective psychological treatment for anxiety and obsessive compulsive related disorders, yet approximately half of patients with these disorders who receive CBT fail to achieve sustained clinical remission. No reliable biomarker of CBT non-response exists. This study will determine whether early changes in a specific biomarker, self-focused attention, will represent a sensitive predictor and potential mechanism of CBT non-response.